Trajectories of structure-function coupling in human brain networks from birth to adolescence and their relationship to transdiagnostic psychopathology

PROJECT SUMMARY/ABSTRACT
Half of all lifetime mental health disorders are present by adolescence, but the neural mechanisms underlying
these disorders, particularly in the period leading up to adolescence, are still poorly understood. Early life and
early adolescence are theorized to be sensitive periods characterized by large changes in structural (white
matter-based) and functional (activity-based) brain networks and during which individuals are at increased
vulnerability for later psychopathology. The correspondence between structural and functional connectivity,
termed structure-function (S-F) coupling, also changes across development and, critically, relates to
psychopathology. However, no studies have yet examined how S-F coupling changes across both sensitive
periods in the same individuals, and it is unknown how S-F coupling relates to risk for psychopathology that
transcends diagnostic boundaries (i.e., transdiagnostically). The proposed study will leverage the UNC Early
Brain Development Study (EBDS), a unique dataset consisting of 10 timepoints of diffusion and resting-state
functional neuroimaging data spanning two weeks to 16 years in the same individuals. This study will
characterize trajectories of S-F coupling between birth and 16 years and will measure psychiatric outcomes at
ages 6, 10, and 16 using the general psychopathology factor (p-factor), which captures transdiagnostic risk for
psychopathology. Critically, 40% of infants in the EBDS dataset were at increased risk for future psychopathology
at enrollment (e.g., due to premature birth, maternal mental illness). Therefore, this dataset is ideally suited for
a longitudinal study examining transdiagnostic outcomes. With these unique data, this project will be the first to
establish how S-F coupling changes across development within individuals and how these changes relate to
transdiagnostic psychopathology. To accomplish these goals, this project will: 1) characterize longitudinal
trajectories of S-F coupling from birth to adolescence, 2) determine what features of S-F coupling in early
childhood, middle childhood, and adolescence relate to transdiagnostic psychopathology cross-sectionally, and
3) determine how trajectories of S-F coupling from birth to adolescence predict transdiagnostic psychopathology
in adolescence. Through the results of these aims, this study will not only advance our knowledge of
neurodevelopmental trajectories across childhood and adolescence, but it will also contribute to the identification
of early neural markers of future transdiagnostic psychopathology. This essential early work may guide future
clinical practice to improve outcomes for children of all ages. The expertise of an exceptional mentorship team
combined with a unique dataset and top-tier resources available at the University of North Carolina at Chapel
Hill will allow the trainee to use this research project and training plan to prepare for a productive career as a
physician-scientist applying advanced neuroimaging analysis to study typical and atypical neurodevelopment.

Public health relevance
PROJECT NARRATIVE Structural and functional brain network development from birth may be key markers for outcomes years later, but there are still considerable gaps in our understanding of both typical and atypical brain development, particularly how structural and functional brain networks interrelate, and whether their degree of correspondence during key sensitive periods may serve as a transdiagnostic marker for psychopathology. This proposal will utilize a single-cohort, longitudinal dataset of diffusion and resting-state functional neuroimaging data from birth to age 16 in a sample enriched for psychopathology to characterize trajectories of structural and functional network coupling across development and relate these trajectories to transdiagnostic psychopathology. Together, this research will improve our understanding of the development of structural and functional networks and how they underpin psychopathology, which may ultimately lead to a better understanding of key sensitive periods in which early screening or intervention should be targeted.